PATHOGENESIS OF HUMAN PITUITARY ADENOMAS

It is hypothesized that pituitary tumor induction may be related to disorder hypothalamic secretion leading to unrestricted, polyclonal pituitary cell hyperplasia. Alternatively, these tumors may arise from a somatic mutation in a single cell, producing a monoclonal tumor. Pituitary tumor tissue is are acquired for genetic and histmorphologic studies. Thus far, RAS mutations have been found to be uncommon.